Basal ganglia circuit mechanisms for threat coping

Project Summary/Abstract
Avoiding potential threats before experiencing disastrous events is critical for survival, yet excessive avoidance
may lead to maladaptive conditions such as withdrawal or missing rewarding events. Abnormalities in threat-
coping may underlie psychiatric conditions including post-traumatic stress disorder and anxiety disorders.
Recent studies have shown a critical role for the sensory part of the striatum, the posterior tail of the striatum
(TS), in avoidance of a potential threat. These studies have indicated that TS-projecting dopamine neurons are
activated by salient threatening stimuli, and animals avoid activation of these neurons. The role of the TS in
threat avoidance has been pursued further using a foraging paradigm (“Monster task”) in which mice are
presented with a potential threat (a moving monster) while they forage for a reward. In this task, although mice
never experienced physical harm, they exhibited three stages of threat-response: initial reactive avoidance,
gradually-acquired proactive avoidance, and eventual overcoming of the threat to obtain reward. Lesions of
TS-projecting dopamine neurons impaired threat avoidance. Further, preliminary results indicate that, in the
TS, medium spiny neurons in direct and indirect pathways (dMSNs and iMSNs) facilitate threat avoidance and
overcoming, respectively. Building on these observations, the goal of this project is to elucidate the neural
mechanisms by which TS and associated circuits of the basal ganglia function to regulate progression of
threat-coping. Aim 1 will test the hypothesis that dopamine in TS represents threat prediction error and
regulates threat-coping by dual modes of functioning, acute and learning-based actions. To this end, dopamine
release in TS will be monitored using fiber photometry or manipulated optogenetically during the Monster task.
Aim 2 will examine the striatal circuit mechanisms by which dopamine regulates threat-coping. The specific
hypotheses to be tested are that (1) the balance between dMSNs and iMSNs determines the behavioral output
(threat avoidance vs. overcoming), and that (2) phasic dopamine signals modulate the balance between these
opponent circuits through both acute and learning-based mechanisms. Finally, Threat-coping can involve at
least two distinct processes: action selection (choosing to approach or avoid) and/or changes in sensory
processing (adjusting the salience of a potentially threatening stimulus). Aim 3 will aim to identify pathways
downstream of TS which are involved in these processes. Specifically, this aim will test the hypotheses that (1)
the integration of dMSN and iMSN activities occurs in the substantia nigra pars lateralis (SNL) which then
regulates avoidance behavior, and that (2) the TS-globus pallidus-thalamic reticular nucleus pathway
modulates sensory representation in lateral geniculate nucleus to attend or overcome a monster threat.
Overall, this study will elucidate a role for novel neural circuits (TS and associated basal ganglia pathways) in
three stages of threat-coping, initial reactive avoidance, proactive avoidance, and overcoming of the threat.

Public health relevance
Project Narrative Threat-coping behaviors evolve over time, as humans and animals initially avoid and eventually learn to overcome potential threats. Abnormality in such dynamic adjustment is thought to underlie various psychiatric disorders such as post-traumatic stress disorder and anxiety disorders. The result of the proposed study will identify novel neural circuits that critically regulate such dynamic adjustment in threat-coping, and thus will provide crucial insights into these psychiatric disorders.